The Undiagnosed Diseases Network Clinical Site of Miami

PROJECT SUMMARY
The Undiagnosed Diseases Network (UDN) is a research initiative that aims to diagnose rare and unknown conditions. However, the UDN has a low representation of minority and underserved populations, especially Hispanics and African Americans. These groups may face barriers to access and benefit from the UDN’s services. To address this gap, the UDN Miami Clinical Site, located in one of the most racially and ethnically diverse regions in the U.S., has been working to increase the inclusion and participation of individuals from these communities. The main objectives of this study are to recruit and enroll at least 40 additional participants annually; mainly from underrepresented populations, perform thorough clinical and research evaluations, and identify novel genetic and non-genetic causes that may explain their undiagnosed conditions. The study will also use a biorepository and conduct telehealth and in-person assessments using advanced medical facilities. The study aims to improve the diagnostic outcomes and reduce the disparities for minority and underserved populations in the UDN. So far, the study has achieved a diagnosis rate of 25% among the completed cases, as well as discovered several candidate genes and repeat expansions that are being validated. The study will continue to enroll and evaluate participants from Florida, which includes people from largely underrepresented groups.

Public health relevance
Narrative We propose to continue the Undiagnosed Diseases Network Miami Clinical Site to evaluate and provide data from over 40 participants annually with various undiagnosed conditions. A major focus will be on enrolling underrepresented minority groups into UDN – an area UDN Miami has been a leader in the current funding cycle. Our team’s combined expertise in genetics and genomics, sensory disorders, robust biorepositories, outreach and ethics ensures the success of this proposal.